HORMONAL STUDIES OF AFFECTIVE DISORDER

Studies of somatostatin and cortisol in relation to affective and other neuropsychiatric disorders have continued. Additionally, other studies have been undertaken including the investigation of progesterone in women with a variety of affective syndromes, beta endorphin in humans and rats administered interleukin-2 (IL-2), dehydroepiandrosterone-sulfate in Alzheimer's and AIDS patients, and pituitary cell culture response to IL-2. A) Somatostatin - In human post-mortem regional brain studies, no difference in concentration of somatostatin was observed in the hippocampus, amygdala, or prefrontal region among schizophrenics, suicides, and controls. Post-mortem CSF studies showed significantly increased ventricular CSF somatostatin in Parkinson's and Huntington's patients compared with controls or Alzheimer's patients. B) Cortisol - Salivary cortisol has been used to study patients and controls undergoing caffeine infusion, patients on carbamazepine, and patients with affective disorder, on a longitudinal basis. C) Other assay measures - Assays for plasma beta-endorphin, salivary progesterone; and CSF DHEAS have been developed to study IL-2 and menses-related affective changes, as well as AIDS and Alzheimer's disease.